Multidisciplinary Training in Cardiovascular Pathophysiology

While new classes of drugs and advances in surgical interventions have led to a decline in the cardiovascular mortality rate, the incidence of cardiovascular disease has begun to rise again in recent years after decades of decline, suggesting a continued investment in biomedical research will be critical to maintaining the progress we have made in fighting this disease. Due to the complexity of cardiovascular disease and the growing availability of advanced research techniques to understand these disease processes, it is imperative that the next generation of research scientists receive training across a variety of disciplines, including cardiovascular physiology, cellular and molecular biology, and disease pathogenesis. However, the state of Louisiana currently lacks any NHLBI funded T32 programs to further graduate training.
The Center for Cardiovascular Diseases and Sciences (CCDS) at LSU Health Shreveport includes a collaborative, multi-departmental faculty with research interests across a wide variety of cardiovascular diseases. To facilitate graduate and postdoctoral training, the CCDS has funded 26 Predoctoral Fellows and 34 Postdoctoral Fellows over the past 8 years. The goal of the Multidisciplinary Training in Cardiovascular Pathophysiology (MTCP) Training Program is to grow and formalize our graduate research program, to meet the need for advanced interdisciplinary training for Predoctoral Fellows, and to provide training in the study of cardiovascular disease. Trainees within the MTCP will be exposed to inter-departmental training initiatives, providing an extensive training experience that complements the individual departmental programs. The MTCP training program will build on current training initiatives in the CCDS to provide the only cardiovascular training program in Louisiana and the only training program in the state focused on disease pathogenesis. The overall goals of the MTCP at LSU Health Shreveport are: 1) to provide opportunities for research training in state-of-the-art research laboratories involving collaborative groups of established and emerging research scientists, 2) to establish a training program in cardiovascular pathophysiology involving didactic lectures, seminars and interaction with world- renowned scientists, clinical research experiences, and multiple annual research events, and 3) to enhance the professional development of our trainees through access to advanced training for grant writing and career skills seminars.

Public health relevance
While new classes of drugs and advances in surgical interventions have reduced the cardiovascular mortality rate, cardiovascular disease incidence has begun to rise again in recent years, suggesting a continued investment in biomedical research will be critical to further reduce residual cardiovascular disease risk. Due to the complexity of cardiovascular disease and advanced research techniques used to understand these disease processes, it is imperative that the next generation of research scientists receive training across a variety of disciplines, including cardiovascular physiology, cellular and molecular biology, and disease pathogenesis. The goal of the Multidisciplinary Training in Cardiovascular Pathophysiology (MCTP) Training Program is to establish a research program to meet the need for advanced interdisciplinary training for Predoctoral Fellows and to provide training in the study of cardiovascular disease.